Predoctoral Training in the Pharmacological Sciences

________________________ ____PROJECT SUMMARY / ABSTRACT __ ____ ___ _________________
The Pharmacological Sciences Training Program (PSTP) at the University of Iowa seeks to achieve
interdisciplinary and integrated training of a diverse cohort of graduate students in Pharmacological Sciences.
The result will be successful PhDs who are well prepared for career and leadership positions in pharmacology
in academia, government (e.g. regulatory agencies), pharmaceutical companies, biotechs, research institutes,
and science-related fields. In addition to training PhDs well-positioned for career success, our outcomes include
publication of first-author and collaborative papers, success in obtaining individual, nationally- competitive
fellowships, at or below-average time to degree, and establishing an inclusive and supportive environment
conducive to intellectual growth and scientific development. This program is built upon a foundation of an
existing Interdisciplinary T32 in Pharmacological Sciences established in 2004, and we build on elements of this
program with new programmatic, evaluation, and curricular plans, which bring greater focus on mentorship, team
science, rigorous and reproducible research, and career development.
The pool of trainees eligible for this program at the University of Iowa is talented and deep. Drawing from
53 mentor laboratories in 13 degree-granting programs across 3 colleges (Medicine, Pharmacy, Liberal Arts &
Sciences), we aim for 6 trainees per year to join our program, each appointed for two years (their 2nd and 3rd
years of graduate study) for a total of 12 trainee positions. We request funding of only 9 positions, however,
because the three participating colleges have pledged support of one matching position each. Our 6 proposed
trainees are selected annually from a large pool of strong applicants (5-year average: 19). Trainee selection is a
holistic evaluation process that considers fairness and diversity, in addition to strength of the applicant.
This PSTP aims to be a highly effective mechanism for interdisciplinary training in the Pharmacological
Sciences regardless of departmental affiliation. Even after financial support ends, trainees remain actively
engaged in the PSTP through and past graduation. Our core course sequence, Principles of Pharmacology and
Pharmacogenetics & Pharmacogenomics, provides trainees a deep understanding of classical and modern
pharmacology. Additional courses are required, such as Advanced Problem Solving in Pharmacological
Sciences, in which trainees work as a team to design collaborative research plans, while Basic Biostatistics and
Experimental Design, and Mastering Reproducible Science focus on rigor and reproducibility, a theme threaded
throughout all activities of the PSTP. Science Communication in the Digital Age and PSTP-organized career
workshops are offerings that broaden the development of career skills to better prepare our trainees for the job
market. These courses lead to cohort-building for our trainees from different programs, as they progress through
classes and program activities together including research retreats, summer brown bag discussion luncheons,
as well as semi- weekly interactions during Pharmacology Seminar.

Public health relevance
___________________ _ ____ ____PROJECT NARRATIVE ___ __ ____ __ __ _____________ The Pharmacological Sciences Training Program (PSTP) at the University of Iowa is an interdisciplinary training program with a goal of training a diverse cohort of Ph.D. students in the pharmacological sciences in order to prepare them for research and research-related careers. We provide our students with foundational and in- depth knowledge of pharmacology as well as hands-on training in cutting-edge research. Rigor and reproducibility, critical self-assessment, and dedication to mentoring of students and faculty at all levels are threads woven throughout our program.